Impact of Disparities in Food Security on Glycemic Control and Health CareUtilization Among Youth and Young Adults with Diabetes

ABSTRACT
Food insecurity affected 11% of all US households in 2020, and youth and young adults with type 1 diabetes
(T1D) or type 2 diabetes (T2D) experience even higher rates of food insecurity, 18% and 31%, respectively.
Moreover, 56% of youth and young adults with T1D and 46% of those with T2D do not achieve optimal
glycemic control, with young people from underrepresented racial/ethnic groups experiencing much higher
rates of poor glycemic control. We propose a continuation of the NIDDK-funded SEARCH Food Security
Cohort Study (SFS 1), which collected data on >1,000 youth and young adults with diabetes and documented
the role food insecurity plays in influencing glycemic control and related outcomes. SFS 1 data indicate that
compared to those who are food secure: (a) young people with T1D and food insecurity have higher HbA1c
(+0.34%, p=0.04) and (b) those with T2D and food insecurity have higher odds of diabetic ketoacidosis (3.1,
p=0.02) in fully adjusted models. However, food insecurity varies day-to-day and ranges from intermittent to
persistent, and SFS 1 did not capture the day-to-day variation, which is needed for intervention planning. Thus,
we propose a research strategy of high scientific rigor that will integrate longitudinal quantitative and
qualitative methods, including ecological momentary assessment (EMA) and continuous glucose monitoring
(CGM), in an intensive, mixed methods study. This proposal (SFS 2) greatly expands our work in SFS 1
toward identifying the temporal causal cascades and actionable and acceptable interventions for eliminating
food insecurity. To achieve these goals, we aim to (1) leverage the ongoing SFS 1 study to enroll a cohort of
360 youth and young adults with diabetes (260 T1D, 100 T2D), 72% with a history of food insecurity, for a
repeated-measures, longitudinal mixed methods study over 9 months; (2) evaluate differences in real-time
glycemic control between participants with varying levels of food insecurity, assessed by average daily time in
range (TIR) via CGM over two 14-day time periods spaced 9 months apart; (3) evaluate the within-participant
impact of food insecurity on TIR and intermediate paths using EMA methods, including dynamic structural
equation models; (4) use longitudinal, qualitative methods to concurrently and deeply characterize the context
of participants’ food insecurity experience and coping process, by conducting a concurrent events study of 30
individuals with T1D and 15 with T2D with a history of food insecurity through in-depth, one-on-one, repeated
semi-structured interviews over 9 months. This study will integrate intensive data collection of the primary
outcome (TIR by CGM) and the primary exposure (daily food insecurity), as well as measures of physical
activity, diet, and mood. These quantitative data will be complemented by longitudinal qualitative interviews,
which will allow us to triangulate the quantitative data with participants’ lived experiences. The findings will
contribute to future interventions and policies that are designed to interrupt the cycle of food insecurity and
poor glycemic control and are effective for and acceptable to young people with diabetes.

Public health relevance
NARRATIVE Good glycemic control is important for optimal health and prevention of acute and chronic complications among people living with diabetes, but food insecurity is a serious barrier to achieving good glycemic control, particularly among underrepresented racial/ethnic groups. This is the first longitudinal study that will characterize how food insecurity affects glycemic control measured by continuous glucose monitoring and the impact it has on health care utilization on a day-to-day basis in youth and young adults with type 1 and type 2 diabetes.